Targeting Metabo-Redox Network Vulnerability in Heart Failure and Sudden Death

Heart failure (HF) is increasing in prevalence and incidence in the US. Despite advances in treatment, mortality is ~50% within 5 years of diagnosis with half of those deaths from sudden cardiac death (SCD), many before ejection fraction has decreased to a qualifying level for an implantable defibrillator (EF35%). There are no effective therapies to specifically treat SCD, apart from a defibrillator, which is palliative, not preventive. The multifactorial nature of HF/SCD requires an approach that considers the integrative physiology of both the myocyte and the organ, and a suitable experimental model with features of the human disease. This project leverages a unique guinea pig HF model that recapitulates many important aspects described in human heart failure, including long QT syndrome, arrhythmogenic SCD, inflammation, extracellular matrix remodeling, impaired Ca2+ handling, metabolic remodeling, and oxidative stress. Employing cellular experiments with a multi-omic approach, our recent and new data provides a comprehensive understanding of the genes, proteins, and fluxes (ionic and metabolic) behind the pathophysiology of HF/SCD. We identified important control points involved in acute emergent events, such as impaired metabo-redox coupling leading to mitochondrial ROS (mROS) overload and SCD, and those that mediate chronic remodeling, characterized by suppression of metabolic and redox transcriptional programs, lowering the threshold for the acute events. Our exciting preliminary data shows that both SCD and HF can be prevented or reversed by treatment with the mitochondrial ROS (mROS) scavenger, mitoTEMPO. For the first time, we show that mROS drives chronic remodeling of the specific phosphoproteome and the expression proteome in HF, likely through mitogen-activated protein (MAP) kinase activation. Remarkably, the design of our mROS scavenger protocol allows us to discriminate between mechanisms impacting SCD risk versus those that alter contractile function. Thus, the overarching goal of this application is to determine which proteins are targets of acute regulation by mROS, contributing to SCD/arrhythmia risk, versus those that are implicated in chronic HF remodeling. We hypothesize that mROS acutely impairs Ca2+ handling and repolarization, but also acts as a second messenger causing negative HF outcomes by disrupting the normal coupling between cytosolic signals and the nuclear gene programs driving mitochondrial function, antioxidant enzymes, Ca2+ handling and action potential repolarization and that the chronic effects of mROS are transduced through activation of MAP kinases. Our aims are to 1) determine protein/phosphoprotein targets regulated by mROS that discriminate between high arrhythmia/SCD risk and the HF state, 2) determine the acute versus chronic contribution of mROS to the electrophysiologic, EC-coupling and ROS abnormalities underlying SCD and HF in myocytes and intact animals, and 3) determine which branch of the MAP kinase family mediates the mROS-dependent uncoupling between cytoplasmic signals and proteome remodeling.

Public health relevance
Heart failure affects almost 6 million people in the US alone, but only a few, partially effective, treatments are available. To understand why heart failure patients die suddenly from cardiac arrhythmias and to develop new treatments, we will determine which genes and proteins change during the progression of heart failure in an animal model that closely mimics the human disease and then test potential therapeutic targets. Our recent discovery that a mitochondrial reactive oxygen species scavenger reverses heart failure and prevents sudden death gives us insight into disease mechanisms that will provide new therapies for this disease in the future.